Mechanisms of sound encoding in the Drosophila brain

DESCRIPTION (provided by applicant): A central challenge in neuroscience is to connect an empirical description of a neural circuit's activity to its role in guiding behavior or supporting perception. In the auditory pathway, our models of neural computations stem from characterizing receptive field properties of neurons along the pathway from periphery to brainstem and cortex. However, neural responses can contain more information about the stimulus than our models predict. Indeed, without precise control over neural activity, testing how well a model predicts a circuit's functional importance can be difficult. With a relatively small, tractable auditory system, Drosophila melanogaster is an excellent model for studying the neural encoding of auditory stimuli. The powerful genetic tools available for Drosophila can allow us to investigate how specific neural computations underlie hearing and communication. Flies detect and respond to natural sounds, and, like humans, use sound to communicate, specifically during courtship. Here I propose to investigate auditory encoding in class of cells called B1 neurons. B1 neurons are responsive to sound and have been shown to be critical for eliciting behaviors that are dependent on courtship song, but little is known about their physiology or responses to auditory stimuli. I will perform experiments to address two specific questions: 1) what features of sound stimuli do B1 neurons encode, and 2) how do molecular and network mechanisms shape B1 neuron sound responses? I will first target genetically labeled B1 neurons for electrophysiological recordings to characterize their responses to sound. I will test how cell-intrinsic properties contribute to B1 sound responses by genetically manipulating their intrinsic excitability. Finally, I will then genetically restrict auditory functon to distinct populations of primary sensory neurons in order to determine the source of B1 input. Together, these aims seek to test whether the population of B1 neurons exhibit diverse but complementary functional properties that permit computation of abstract features of sound.

Public health relevance
PUBLIC HEALTH RELEVANCE: Many forms of deafness have a genetic component, but the mechanisms by which deafness genes affect hearing are to a large extent unknown. Properly functioning ears of flies and humans depend on a common molecular toolkit, which includes developmental genes, mechanosensitive channels and motor proteins, among others. Together with the genetic tools for working with Drosophila and the fly's compact neural circuitry, these commonalities make Drosophila an ideal organism in which to test the function of candidate deafness genes and to relate mutations in these genes to deficits in auditory behavior, but to do so, we must develop our understanding of how the fly auditory system encodes sound.